Illuminating multiplexed RNA dynamics to interrogate splicing in health and disease

Ribonucleic acids (RNAs) play key roles in numerous cellular processes. A classic example is alternative
splicing, where the large megadalton spliceosome complex removes intron regions from the pre-messenger
RNA (pre-mRNA) and re-joins the exons to form the mature mRNA in the nucleus. The spliceosome consists
of protein and non-coding RNA components. Its assembly includes intricate maturation steps that are highly
regulated to ensure that the correct mature mRNA molecules are produced at the right time in healthy cells.
Achieving correct splicing of all mRNAs is subject to intense regulation, requiring a sophisticated interplay of
cellular cues and spatiotemporal dynamics of splicing components. Genetic mutations or environmental
stressors are perturbations that may affect the splicing process and outcomes. These are linked to human
disease states like cancer and neurological diseases. Together, the central role of complex spatiotemporal
RNA dynamics for proper splicing calls for the need to interrogate diverse RNAs live on a subcellular level over
time. The complexity of RNA species involved in splicing requires robust and versatile labeling strategies to
visualize multiple RNA molecules simultaneously and relative to other biological molecules of interest. A key
goal of this research program is to develop such a robust toolbox for multiplexed RNA visualization using
advanced fluorescence microscopy. Fluorescence lifetime imaging microscopy (FLIM) emerges as a
particularly versatile approach, as it is compatible with adding sophisticated imaging modalities. A central
feature that will be included in the proposed work is the ability to visualize multiple RNAs simultaneously,
including small non-coding RNAs with roles in splicing. More broadly, these RNA imaging tools will allow
researchers across different fields to investigate RNAs in a variety of relevant cell model systems. Alternative
splicing has been linked to formation of a type of cytosolic RNA-protein granules, called U-bodies.
Spliceosome RNAs (called U snRNAs) are the defining components of U-bodies, along with several proteins
that are implicated in the splicing reaction. U-bodies were observed across different cellular models, pointing to
a central role in gene regulation, but details about their precise composition and function remain elusive. This
research program will combine targeted investigation of U-bodies and the newly developed multiplexed RNA
fluorescence tagging tools to delineate mechanistic roles of U-bodies. U-body compositions and their
subcellular dynamics upon perturbation will be defined to delineate underlying cellular mechanisms. A possible
link between U-body dynamics and alternative splicing regulation will be investigated. As a long-term goal, the
role of U-bodies in splicing dynamics and regulation may be expanded upon across biological cell systems and
perturbations, revealing a previously unknown new layer of gene regulation. U-body components have been
linked with several human disease states, indicating that insights from this research program may shed light on
possible treatment and disease management strategies of human health in the future.

Public health relevance
Roles of ribonucleic acids for diverse functions in cellular processes continue to be discovered, calling for sophisticated approaches to investigate these central molecules in living cells. Splicing describes the process of diversifying gene expression, and a diverse group of RNAs is involved in this complex process that requires precise regulation in space and time. This proposal aims to expand the toolbox to interrogate ribonucleic acids live in mammalian cells using fluorescence microscopy and use them as the foundation for new insights in splicing function and regulation in health and disease states.